Reducing PFAS Exposure Through In-situ Microbial Remediation of PFAS Impacted Matrixes

Project Summary
Ongoing and legacy use of highly persistent per- and polyfluoroalkyl substances (PFAS)
has led to widespread environmental contamination across the US. Emerging insight into the
adverse health impacts of PFAS exposure has resulted in intense scrutiny of PFAS
contamination, stringent environmental regulations, and massive liability. PFAS in food and
drinking water are major sources of human PFAS exposure. Food products from PFAS-impacted
agricultural land can contain PFAS concentrations that are hazardous to human health.
Nationally, an estimated 20 million acres of agricultural land are impacted with PFAS, mainly
due to applications of PFAS-impacted biosolid fertilizer and the use of irrigation sources
contaminated with PFAS. Discharge from industrial activity and the use of firefighting products
containing aqueous film-forming foam (AFFF) can also directly contaminate soil. Impacted soils
can leach PFAS into drinking water sources, further harming human health. While several
physical and/or chemical methods have shown promise for destruction of PFAS in soil, the
feasibility of scaling these technologies is uncertain due to high cost, high energy use, and/or the
use of hazardous chemicals for PFAS extraction and destruction. Current approaches for
remediation of soil include PFAS stabilization and soil removal. Neither of these existing
approaches permanently destroy PFAS, creating the potential for further harm to human health.
Microbial-mediated bioremediation represents a scalable, cost-effective in situ alternative to
current remediation approaches. BluumBio has identified two soil microbes which rapidly
degrade diverse PFAS, including the six PFAS currently regulated by the US Environmental
Protection Agency. This project seeks to develop a product formulation which supports optimal
viability of both PFAS degrading microbes in soil environments. Our final powdered product
formulation will contain dried PFAS-degrading microbes with nutrients necessary for microbial
viability and bioactivity and will be mixed with water for applications on soil. We will
characterize in situ PFAS degradation resulting from applications of microbial product
formulations on PFAS-impacted soil samples in laboratory treatability studies. Following
microbial-mediated PFAS degradation, we will characterize fluorinated breakdown products
resulting from biodegradation. Our laboratory treatability studies will inform product application
guidelines towards future large scale field trials. Our project will produce a scalable, microbial
based solution for in situ remediation of PFAS-impacted soils. BluumBio’s novel PFAS
bioremediation solution will reduce exposure to PFAS and directly improve human health.

Public health relevance
Project Narrative Per- and polyfluoroalkyl substances (PFAS) are widespread environmental contaminants that present an urgent and severe threat to human health. Currently, there are no practical or commercially available strategies for in situ or ex situ remediation of PFAS-impacted matrices. BluumBio’s scalable, cost-effective solution for in situ treatment of PFAS-impacted matrices will reduce human exposure to PFAS and improve human health.